Epigenetic, Telomere & Chromosome Changes in Adult Twins Having Child Adversity

DESCRIPTION (provided by applicant): Psychosocial influences have been implicated in the etiology of several of the most common illnesses impacting human health (cardiovascular disease; diabetes; cancer). It has been hypothesized that these psychosocial effects are mediated through DNA-based biological changes, such as methylation alterations or telomere attrition. However, due to the paucity of research in this area, many questions remain: To what extent do epigenetic and acquired genomic changes accumulate over the human lifespan? Do childhood adversities result in biological changes that persist into adulthood? Can an adult who was exposed to childhood adversities be identified as at risk for developing disease based on their epigenetic, gene expression, telomeric, chromosomal instability, and/or cortisol level profiles? To answer these questions we will study 736 twins who have completed intense phenotypic behavioral evaluations in previous studies (completed 2 to 15 years ago) and represent two risks groups: (1) twins experiencing the extreme childhood adversity event of sexual abuse; and (2) twins experiencing a broad spectrum of social experiences. Cohort 1 (ages 40-55) will comprise a selected sample of 50 identical twin pairs who are discordant for a history of childhood sexual abuse, as well as 50 identical concordant pairs who did (25 pairs) or did not (25 pairs) experience sexual abuse as a child. The biological endpoints that will be measured and compared between co-twins for this cohort include: (1) frequencies and locations of genome-wide methylation changes using a sequence-based approach; (2) chromosome-specific telomere lengths; (3) frequencies of acquired chromosomal instability; (4) patterns of gene expression; and (4) diurnal basal salivary cortisol levels. Cohort 2 (ages 20-30) will be comprised of a normative sample of monozygotic (157 pairs) and dizygotic (111 pairs) twin pairs for whom behavioral phenotypes have been carefully determined throughout adolescence into young adulthood. The data gained from the study of these twins will provide insight as to the potential cumulative effect of multiple adversities on embedded biological changes. The biological endpoints to be measured for this cohort (for whom blood samples have been previously collected and are readily available) include: (1) frequencies and locations of genome-wide methylation changes using array based methodology; and (2) gene expression patterns. Collectively, comparisons of observed alterations in biological endpoint measures (within and between twins) to phenotypic data collected from multiple stages in the human lifespan will allow us to deduce the extent to which the observed differences in biomarkers are influenced by childhood adversity, adult adversity, and/or other environmental stressors. The data from this investigation will lead to the first direct estimate of the frequency of epigenetic, telomere length, acquired chromosomal instability, gene expression, and/or cortisol level changes that arise in adults due to childhood adversities.

Public health relevance
PUBLIC HEALTH RELEVANCE: The potential that environmental and social events can be biologically "remembered" to result in an individual having an increased risk for developing health conditions many years later has only recently been recognized. In this study we will identify potential mediators of this biological memory by recognizing changes in genomic and epigenomic patterns that are acquired in adults as a result of adverse (as well as positive) childhood events. By collecting this information from our unique population of twins, which includes a selected sample of discordant identical pairs, as well as a population sample of identical and fraternal twins, we can determine if observed behavioral and health outcomes are associated with specific genetic or epigenetic changes. The data collected from this study will establish a relationship between the long-term, cumulative biological effects of early-life stresses on disease. Moreover, the information gained from this study could be exploited to develop a biomarker assay to recognize individuals who are at "at risk" for acquiring illnesses, and/or lead to the development of therapeutic interventions to reduce adverse health outcomes. NARRATIVE The potential that environmental and social events can be biologically "remembered" to result in an individual having an increased risk for developing health conditions many years later has only recently been recognized. In this study we will identify potential mediators of this biological memory by recognizing changes in genomic and epigenomic patterns that are acquired in adults as a result of adverse (as well as positive) childhood events. By collecting this information from our unique population of twins, which includes a selected sample of discordant identical pairs, as well as a population sample of identical and fraternal twins, we can determine if observed behavioral and health outcomes are associated with specific genetic or epigenetic changes. The data collected from this study will establish a relationship between the long-term, cumulative biological effects of early-life stresses on disease. Moreover, the information gained from this study could be exploited to develop a biomarker assay to recognize individuals who are at "at risk" for acquiring illnesses, and/or lead to the development of therapeutic interventions to reduce adverse health outcomes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Investigators have postulated that early-life stress events are a risk factor for the acquisition of several age-related health problems including cardiovascular, respiratory, and/or infectious diseases (Miller et al. 2009). The observation that adults who experienced adverse childhood events die nearly 20 years earlier than those without a history of childhood adversity underscores the impact of these events on human health (Brown, et al. 2009). Clearly, early-life stress events are a major factor contributing to morbidity and mortality. However, little is known about the biological changes that arise and are "remembered" throughout one's development to lead to an increased risk for morbidity several decades later. One potential means for childhood social experiences to be biologically embedded and to have a pathologic consequence as an adult would be if that event resulted in a change in the individual's DNA; either structural or functional. Furthermore, if these purported DNA changes demonstrated plasticity, their recognition could provide a means for reversing disadvantageous alterations, thereby reducing one's health risk in adulthood. Thus, the primary goal of this study is to determine if a history of childhood adversity is associated with the acquisition of genomic and/or epigenomic changes that persist into adulthood. To meet this goal, we will analyze DNA-based changes in samples collected from 736 twins. Twins will be studied because they provide one of the most robust methods for identifying sources of variation (genetic versus environmental) in humans. Twins who experienced one of the most traumatic forms of childhood adversity, childhood sexual abuse (CSA), will be ascertained for cohort 1 (100 twin pairs). We will also study twins (cohort 2) who experienced varying severities of adverse childhood experiences (such as parental neglect; interparental violence; marital discord), to assess their biological impact (not just extremes)(268 twin pairs). The twins for these cohorts will be ascertained through their participation in two previous studies in which their behavioral phenotypes and environmental risks were fully characterized. The twins in cohort 1 are currently 40-55 years old and participated in a study led by Dr. Kendler (15 years ago). The twins in cohort 2 are currently 20-30 years old and participated in an investigation led by Drs. Eaves and Silberg, which has been ongoing since these twins were 8 years old. Thus, by studying twins from these cohorts we will gain information about the impact of the severity of childhood adversity on DNA-based changes, as well as information about differences in the biologically embedded changes that are present over the lifespan of people who experienced childhood adversity. The specific aims of this study are presented below. Aim 1: Determine if there are differences in the frequency and genomic location of DNA-based changes that are present in adult twins (ages 40-55 [cohort 1]) who have a history of childhood sexual abuse, when compared to their genetically identical co-twins, who were not abused. Studies of discordant identical twins, whose DNA differs only for changes that have arisen from varied environmental exposures and/or stochastic events, provide a unique opportunity to recognize acquired DNA- based changes. Therefore, we will study discordant identical co-twins (50 pairs), as well as concordant pairs who have (positive controls) or have not (negative controls) experienced CSA. The biological endpoints that will be compared between these identical co-twins include: (1) epigenetic changes; (2) telomere length shortening; (3) acquired chromosomal instability; (4) gene expression alterations; and (5) basal salivary cortisol levels. By comparing the results of the biomarker assays with previously collected phenotypic data, we will determine if there are genome-wide or locus-specific differences in DNA-based alterations that are accumulated in adults in response to a history of CSA, independent of other risk factors. Aim 2: Determine if there are differences in the frequency and genomic location of methylation and/or gene expression changes that are present in adult twins (ages 20-30 [cohort 2]) having childhood adversities that are representative of the spectrum of population-based experiences. By studying monozygotic and dizygotic twins for whom a broader spectrum of childhood adversity has been defined, the potential cumulative impact of multiple adversities on embedded biological changes will be assessed, as well as the heritability of biological responses to these events. The DNA-based changes that will be evaluated between and within pairs from this cohort (for whom blood samples have been previously collected and are readily available) include: (1) epigenetic changes; and (2) gene expression alterations. The collective information gained from the successful completion of these aims will allow for recognition of the extent to which the observed differences in biomarkers are related specifically to childhood adversity, adult adversity, and/or environmental stressors. Thus, by coupling information gained from studies of cortisol levels and DNA-based changes with information collected in our rich database of phenotypic characterizations, this proposal will provide a lifespan approach to recognizing the impact of childhood adversity on adult health.